J: Penn State NRSA Training Core

PROJECT SUMMARY/ABSTRACT-PENN STATE NRSA TRAINING CORE
Translation of scientific discoveries into effective clinical interventions and best practices to improve public health
is a complex process transcending traditional disciplines. The goal of the Penn State Clinical and Translational
Science Institute (CTSI) TL 1 Training Core is to provide early career scientists with the interdisciplinary training
needed to conduct collaborative translational research aimed at transforming knowledge to benefit human health.
Our program provides opportunities for predoctoral trainees to gain a foundation in clinical and translational
science (CTS) through competency-based, didactic, experiential, mentored training opportunities coupled with
career development activities. Drawing students from both the College of Medicine (CoM) and University Park
(UP) campuses, the TL 1 program is a forum for communication, collaboration, and cross-fertilization of ideas
among students from diverse backgrounds and disciplines including biomedical sciences, medicine, nursing,
nutritional sciences, biobehavioral and social sciences, and bioengineering. In the past funding cycle (2016-
2019), we trained 27 students in our year-long program (22 PhD, 3 MD/PhD, 1 MD/MPH, 1 MD) and 40 students
in our summer program (19 PhD, 21 MD). In this renewal application, we request support for 6 year-long trainees
and 16 short-term trainees per year. Trainees in the 1-year program pursue studies leading to a certificate in
Translational Science, a MS in Clinical Research, or a unique dual-title PhD in Clinical and Translational
Sciences. Training is customized via individual development plans and enhanced by externships and experiential
clinical research, development of leadership, communication, and time management skills, and activities focused
on team science, entrepreneurship, regulatory science, and community engagement. A short-term training is
offered in summer to a mixed cohort of medical and graduate students who are introduced to the fundamental
aspects of CTS in a highly interactive format while conducting mentored research projects. We now seek to
enhance the TL 1 program with aims to: 1) Expand and enhance Penn State's community of predoctoral trainees
engaged in CTS by increasing disciplinary, racial/ethnic and other elements of diversity of trainees by working
with the directors of existing undergraduate pipeline programs, and by developing a new internal pipeline
program to Diversify Research Training in Clinical and Translational Sciences (DiReCTS); 2) Provide
customized, competency-based didactic and experiential training through externships and training in
collaborative team science, coupled with career development activities, structured mentor/mentee training, and
networking activities across CTSA Hubs with shared interests in rural health and health disparities; and 3)
Increase the quality and effectiveness of our CTS training by using a data-driven decision-making approach
involving assessment of the trainees, their mentors, and program outcomes including via CTSA common metrics.